Admin Core

Project Summary Administrative Core
The Administrative Core, through the development and implementation of strategic
integrated management systems, will work to support the Center of Excellence for the
Development and Testing of Point-of-Care Tests (POCT) for Sexually Transmitted
Diseases (STDs). We will lead, support, and assist our Cores to integrate and build
multidisciplinary partnerships; to ensure outreach and communications to guarantee the
inclusion of diverse expertise investigators, industry scientists, and engineers; to evaluate
performance and guide performance improvement; and to cultivate service excellence in order
to reach our Center's overall goals and specific aims, as well as the goals of the POC
Technologies Research Network. The goals of our Administrative Core include addressing the
epidemics of STDs/HIV in the U.S. and in low and middle income countries by development and
better use of Point-of-Care (POC) tests, to address health inequity and improve sexual health.
1. We will support the Center of Excellence and all the individual Cores by assisting them for the
development and verification of POC technologies via collaborative efforts that merge scientific
and technological capabilities with clinical need and training of developers, as well as end
users of POCT. 2. We will support the Cores as they use clinical drivers of technology
progression for developing new and expanding existing POC Tests, by providing assistance
insure that milestones for each project are met. 3. We will help to implement functioning core
components that work smoothly together in a collaborative fashion and with other members of
the Point-of-Care Technologies Research Network (POCTRN). 4. Our Administrative Core will
implement a smooth transition along a pipeline from developmental of prototype assays
through early in-house, clinical translation and validation testing. 5. Our operational
administration will assist Cores to ascertain needs of end users of POC, train scientists, fund
scientists and biomedical engineers for development of prototype and mature POC
technologies, as well as pilot test and validate POC tests in diverse clinical settings. In this
coordinated manner, we can assist with the logical development of POC assays, which will have
sufficient scientific merit to progress to FDA submission and ultimate commercialization.